Drug delivery platform for ocular allergy therapy

PROJECT SUMMARY
Among the estimated 165 million worldwide contact lens wearers one third experience itchy eyes from seasonal
or perennial allergic conjunctivitis. Prevalence of ocular allergy has also risen in part due to environmental
changes related to increased carbon emissions and the contributory role of air pollution in conjunctival
immunological response. Topical anti-allergic agents with multiple mechanisms of action such as ketotifen and
olopatadine are currently recommended as the first-line agents. Olopatadine drops have proven to be more
effective than ketotifen to relieve the symptoms and signs of allergic conjunctivitis] and to provide more ocular
comfort at application. Contact lens wearers are frustrated that ocular allergy interferes with normal wear and
often rely on eye drops to manage symptoms which they find frustrating. The recent and first approval in the U.S.
of a medicated contact lens that addresses this market is Johnson & Johnson's ACUVUE® Theravision™ with
ketotifen medicated daily disposable hydrogel lens. We propose to further develop a next-generation, 1-day drug
delivery contact lens (DDCL) platform for olopatadine using boundary charge modifiers to extend and control
drug release. The work will build on our previous accomplishments in the field—enabling the use of both the
most efficacious allergy drug and the most breathable lenses. The recent Johnson & Johnson product requires
compromises in both areas to accomplish just a few hours (~2 h) duration of release. Lynthera's technology
enables a boundary surface modification scheme to directly incorporate anionic long-chain fatty acids in silicone
hydrogel contact lens' internal nanodomains to house nearly 80% of cationic charged drugs in the polymer-
aqueous pore interfaces of a lens. Our modification scheme will substantially raise olopatadine retention at these
interfaces due to electrostatic interactions between fatty acid anions with olopatadine cations, thereby raising
the precision, duration, and resultant efficacy of olopatadine drug delivery, as well as prolonging comfortable
wear time due to the silicone hydrogel lenses oxygen transmission. With the key aims of Phase I substantially
completed, Phase II will focus on pre-clinical development of its technology platform for a daily disposable, drug
delivery contact lens with olopatadine. Our specific aims are: (1) to optimize a 1-day silicone hydrogel DDCL that
delivers 5 to 22 µg olopatadine with a sustained in vitro release profile for at least 12 hours, while maintaining
requisite commercial standards for optical transmission, oxygen transmissibility and shelf-life; (2) the DDCL
prototype will be evaluated by two in vivo studies of New Zealand rabbits including a small-scale, pilot
pharmacokinetics and one-month toxicology, the latter of which is required to support the IND filing; (3) regulatory
development of the DDCL for an Investigational New Drug (IND) filing with key activities to include pre-IND
meeting and planning and design of a clinical trial. For the commercialization strategy, we have agreement with
a global contact lens company to manufacture and supply the DDCL.

Public health relevance
PROJECT NARRATIVE Among the estimated 165 million worldwide contact lens wearers, approximately one third of these suffer from allergies but face a challenge as the application of eye drops is generally incompatible with lens wearing. We propose to develop a next generation, 1-day drug delivery contact lens (DDCL) for olopatadine using boundary charge modifiers to extend and control drug release –the work will build on the Lynthera project team's previous accomplishments in the field – enabling the use of the most efficacious allergy drug and the most popular contact lens material (silicone hydrogel). A daily disposable DDCL with prescription and loaded with olopatadine can sustainably deliver high-precision dosage for at least 12 hours to relieve allergy symptoms.